Testing a Mobile App to Improve Toothbrushing Skills and Habits in Teens with Autism.

Project Summary/Abstract
One in 60 U.S. children has autism and many are at high risk for poor oral health – a problem that could be
addressed in part through improved toothbrushing. Technologies like mobile health apps are an ideal platform
to deliver toothbrushing interventions, but few app-based interventions have focused on teens with autism and
the work to date has critical limitations. Our team developed an interactive toothbrushing training app called
Brush Up, which incorporates concepts from Video Self Modeling. The app helps users develop toothbrushing
skills through repeated self-observation and interactions with a cartoon exemplar that reinforces correct
brushing. A front-facing (“selfie”) camera on the mobile device displays the child’s face and teeth. Children
brush in tandem with the cartoon exemplar. We tested the app with typically developing children ages 5 to 6
years and found significant improvements in toothbrushing duration after only one week of app use. We then
piloted the same app in individuals with autism ages 4 to 22 years. Caregivers of teens with autism were
particularly enthusiastic about the app and recommended ways to make the app more autism-friendly by
including features that account for sensory sensitivities common in autism. We further identified missing app
features that if included would increase the odds of long-term behavior change. In this 6-year UG3/UH3 grant,
we have 2 Aims: (1) Pilot the app-based intervention; and (2) Conduct a Stage II efficacy trial. During the 2-
year UG3 phase, we will use the Discover, Design+Build, and Test Framework to modify our existing app to
make it autism-friendly, develop a control app with only a digital mirror and timer, pilot the intervention with 40
adolescents with autism ages 10 to 17 years (Waisman score ≥21), and make necessary adjustments. In the
4-year UH3 phase, we will recruit 270 adolescents with autism, randomize participants to 1 of 2 arms, and
compare outcomes. The trial will last 3 months. The primary outcome is toothbrushing distribution, defined as
the mean proportion of tooth surfaces brushed during the last month of the 3-month intervention and measured
in each arm by the respective app. Secondary outcomes are toothbrushing duration and frequency. We
hypothesize adolescents in the experimental arm will exhibit better toothbrushing distribution, duration, and
frequency than those in the control arm. App data will be collected continuously during the 3-month trial and up
to 3-months post-trial. Survey data will be collected at baseline, 2 weeks, 1 months, 2 months, and 3 months to
assess mediators (e.g., self-efficacy) and exploratory outcomes (e.g., habit formation, quality of life). Post-trial
surveys will assess long-term change and interviews with 60 participants from the 2 arms will identify ways to
further improve the intervention. If found to be efficacious, our findings could address an unresolved problem
that affects over 1.2 million U.S. children and teens with autism. Our long-term goal is to develop
comprehensive strategies to prevent caries and reduce oral health inequities that affect teens with autism.

Public health relevance
Project Narrative According to the U.S. Centers for Disease Control and Prevention, 1 in 60 children have autism. The high rate of poor oral health in teens with autism and the considerable lifetime costs of preventable oral diseases underscore the importance of behavioral intervention research aimed at improving toothbrushing skills and habits. The proposed work is a critical first step in helping teens with autism develop long-term toothbrushing habits to prevent tooth decay, improve quality of life, and reduce well-documented disparities in oral health.